Diversity Supplement

Project Summary/Abstract
This is a proposal for a diversity supplement to T32 DC000030. The applicant fits the mission of the T32, as a
productive, well-trained basic researcher in developmental psycholinguistics who will receive training applying
this research to clinical practice. The applicant will receive training in working with typically-developing children
and children with language delays, advanced training in statistical methods, and in training in manuscript and
grant-writing. The applicant meets the criterion of being from an underrepresented population, and will increase
the diversity of our program, as well as bringing a diverse perspective to research on early language
comprehension and learning in children with typical development and language delay.

Public health relevance
Project Narrative The number of successful researchers working in the area of deafness and other communication disorders is not sufficient to meet current needs. In addition, more diversity is needed in the pool of researcher. In this application for a supplement, we propose a training program designed to broaden the research skills of a diverse basic scientist to the study of communication disorders.